Development and Implementation of Safety Planning to Reduce Suicidality in Adolescents Seeking Care in Rural Emergency Departments

One-in-five children and adolescents in the United States (US) live in rural areas where they experience approximately two times the risk of suicide compared with their urban-residing peers.
Despite having increased rates of mental and behavioral health conditions, less than half of rural residing youth with these conditions receive necessary treatment, due in part to shortages of
pediatric services and clinicians. Given barriers to community-based mental healthcare, youth with suicidal ideation and/or attempt increasingly present to emergency departments (EDs) for
care. While several national organizations endorse safety planning (a brief intervention that involves identification of coping strategies, social supports, and lethal means restriction) in EDs
as an evidence-based suicide prevention intervention, implementation in rural settings requires consideration of the unique rural context as well as hospital and community resources. The
overall goal of this project is to develop and implement a technology-aided approach to safety planning that will specifically address two dimensions of health – home safety and access to
community mental healthcare – to decrease suicide risk in youth 12-17 years of age who present to rural EDs. To achieve this goal, investigators will: (i) conduct focus groups and interviews with
rural-residing youth, their caregivers, clinicians, and community members to ascertain their priorities and perspectives about how to optimize safety planning, including lethal means
counseling and community resource connections, in rural EDs; (ii) apply principles of human centered co-design to develop and test a youth- and caregiver-facing tablet-based digital
intervention to guide safety planning, using mixed methods to investigate its feasibility, acceptability, and appropriateness, and to evaluate participant-reported self-efficacy to improve
suicide-related coping and home safety (target mechanisms); and (iii) conduct a type 1 hybrid implementation-effectiveness study using a hospital-randomized stepped wedge design in four
rural EDs to determine the effectiveness of this intervention compared to usual care for youth with suicidality, evaluating the extent to which outcomes are mediated by caregiver and youth selfefficacy,
and assessing the reach, adoption, implementation and maintenance of the intervention using a mixed methods approach. Primary outcomes, measured one and three months following
the ED visit, will include youth-reported suicide risk, evaluated using a validated instrument, and caregiver-reported home safety.

Public health relevance
Children and adolescents who reside in rural regions of the United States experience substantially increased risks of mental and behavioral health conditions and suicide, while also experiencing unique barriers to care given geographic isolation and shortages of mental health professionals. This research will develop, implement, and evaluate technology-assisted, contextually-appropriate safety planning in rural emergency departments for youth with suicidal ideation or attempt and their caregivers, aiming to improve home safety and connections to community-based resources and ultimately decrease youth suicide risk.